Synaptic Organization and Modulation of Kainate Receptors: Investigating the Structure, Dynamics, and Function in the Context of Trans-Synaptic Junctions

Abstract
Kainate receptors are members of the ionotropic glutamate receptor family and are implicated in epilepsy and in
multiple neurocognitive deficits such as autism, schizophrenia, and mental retardation. These receptors can be
found to express in the presynaptic membrane where they regulate neurotransmitter release and postsynaptic
membrane where it is involved in excitatory signaling. These channels are calcium-permeable and, therefore,
activation by glutamate lead to intracellular calcium signaling and synaptic response. However, their current
activity can be modulated by protein interactions. Such interactions can lead to increase steady-state currents,
causing increase calcium permeability and differential synaptic response. Recently, presynaptic Neurexin3β and
extracellular scaffolding C1q-like protein have been revealed to create a junction with postsynaptic kainate
receptors at mossy fibers-CA3 synapses. These interactions have been found to regulate kainate receptor
recruitment at the membrane, however, their modulatory effect on kainate receptor gating properties still remains
unknown.
For my dissertation work, I propose to study how protein interaction at the extracellular domain of kainate
receptor modulate their gating properties. As part of the F99 training, I will use electrophysiology to investigate
the current modulation caused by interactions with Neurexin 3 and C1q-like protein and investigate the
conformational changes using smFRET (Aim 1). This work will give us more insight into the gating mechanisms
caused by the modulation of these proteins and help explain the role of these junctions in postsynaptic excitatory
signaling.
For my training as a post-doctoral student, I intend to continue exploring the macromolecule contacts between
these junctions using electron microscopy. Therefore, for the K00 phase of this proposal I plan to train in
performing CryoEM and CryoET experiments. Using these technologies will allow me to investigate the
connections made between these proteins in the context of these synaptic junctions (Aim 2). The information
obtained in these experiments will give us insight into the structure and organization of this junctions within the
synaptic cleft and further our understanding of the role these junctions play in synapse morphology.
Understanding this will allow us to correlate biological disruption of this junction to behavior deficits.
In summary, the objective of this proposal is to give me the training necessary to investigate the functional and
structural function of these junctions to understand their role in physiological conditions. The training proposed
under this proposal alongside my previous training will give me the framework necessary to become an
independent investigator.

Public health relevance
Project Narrative Kainate receptors are ionotropic glutamate receptors important in synapse regulation and have been linked to neurological deficits including epilepsy, autism, mental retardation, and schizophrenia, making them important as pharmacological targets. Postsynaptic kainate receptors have been found to create a trans-synaptic junction with presynaptic Neurexin3β and extracellular scaffolding C1q-like protein as an intermediate. This proposal aims to investigate the functional and structural properties of this junction in order to understand the role this trans-synaptic junction plays in neuron function and correlate this junction with known behavioral deficits.